Development of a novel kit for reduction of aerosolized particles during endonasal surgeries: the PharynVac Device

Project Summary
Sinonasal surgery is extremely common (>600,000 outpatient procedures annually). There are three issues
that can be mitigated with a single device: surgical staff pathogen and toxin exposure, patient blood ingestion,
and periodic obstructed endoscopic visualization. Only blood ingestion has a current solution: packing the
pharynx with absorbent materials with regular associated adverse events. Here we propose the further
development of PharynVac, a balloon aspiration catheter that simultaneously addresses all three of these
problems passively. If successful, PharynVac will decrease surgical staff exposure, reduce post-procedure
nausea, and minimize operative times, potentially becoming a standard sinonasal surgical tool. This Phase I
application would allow for the implementation of GMP (SA1), demonstrated blood and particle aspiration in a
bio-realistic oral/nasal model (SA2), and demonstrated device safety/feasibility in a large-animal sheep model
(SA3). At this point, PharynVac will move into Phase II: FDA engagement and first-in-human clinical trials.

Public health relevance
Project Narrative Current sinonasal surgery exposes staff to pathogens and toxins, causes avoidable patient nausea, and suffers from obstructed endoscopic visualization. Here we describe the further development of a novel oral/nasopharyngeal balloon aspiration catheter to solve these existing problems in the sinonasal surgical space.